CRCNS: Acetylcholine and state-dependent neural network reorganization

Disrupted sleep is a major predictor of disordered cognition and affect, yet many questions regarding sleep's role in
brain function remain unanswered. For example, why is sleep critical for memory consolidation? Why is there
ubiquitous (presumably, evolutionarily conserved) wake-non-rapid eye movement (NREM)-REM sleep state
ordering across species, and what are the differential roles of the two sleep states? How do brain circuit-wide
dynamics change during these states, and how do those transitions affect the process of memory consolidation?
Wake, NREM, and REM states generate distinct patterns of functional connectivity, which may help to reorganize
brain networks in the context of memory storage. However, multiple mechanisms could play a role in this process,
including state-driven structural (synaptic) changes, neuromodulatory processes, spike timing, or input alterations.
This proposal advances the novel hypothesis that sequential in brain networks' acetylcholine (ACh) signaling and
input properties, associated with wake->NREM->REM state transitions, are essential for memory storage In this
framework, each state plays a distinct role, associated with state-specific network excitatory/inhibitory balance and
neurons' input-response properties. Together, this leads to differential circuit activation and dynamic properties
during wake, NREM, and REM. Our preliminary network modeling data suggest that the specific properties of NREM
and REM allow for recruitment of neuronal populations into individual engrams (NREM), and generation of distinct,
segregated engram representations (REM). These features become critical during consolidation of one or multiple
memories, respectively. Here, we propose to apply computational modeling, in vivo experimentation and analytical
tools to identify NREM (low ACh) and REM (high ACh)-associated dynamical states, and the specific contribution of
these states to information storage in neural circuits. Specifically we will: 1) measure state-associated ACh effects
on functional network connectivity and dynamics in highly reduced in silico neural network models, 2) test effects of
state-targeted manipulations to hippocampal ACh inputs and excitatory-inhibitory balance during consolidation of
one, or multiple, sleep-dependent memories, and 3) develop a predictive in silico model of the hippocampal circuit's
reorganization during memory encoding and subsequent wake->NREM->REM transitions. These studies will also
clarify state-specific mechanisms of memory storage in the brain, and how the wake-NREM-REM sequential
ordering of these states (ubiquitous across vertebrate species) contributes to the process of memory consolidation.
These studies will address Objective 1.1. of the NIMH Strategic Plan for Research, by identifying brain
state-dependent neural circuit mechanisms underlying sleep's role in promoting healthy cognition and memory
storage.

Public health relevance
The proposed studies will provide new insights into how sleep uniquely contributes to long-term memory storage. This work has the potential to lead to targeted interventions for cognitive dysfunction induced by sleep loss, and interventions for psychiatric disorders where both sleep and cognition are adversely affected, including schizophrenia, depression, autism, post-traumatic stress disorder, and dementia.